Exposure to Firearms and African American Youth Suicide by Firearm: A Social Ecological Framework

PROJECT SUMMARY
Suicide is the second leading cause of death for African American youth. From 2001 to 2017,
suicides increased for African American youth by 60% for males and 182% for females.
Additionally, studies find a racial disparity in suicide between African American and white
children. Firearms are the leading method of suicide in this population. Firearm safer storage
and possession of firearms shows substantial variation across place and time. However, the
influence of state policies and regional factors on youth suicide by firearm remains unknown. My
research will provide a social ecological framework for investigating these relationships. All aims
will focus on African American youth. Aim 1 will assess whether state-level safer storage
policies correspond with changes over time in the risk of suicide by firearm and the racial
disparity. Aim 2 will use fine-grained information on urban school districts to estimate whether
carrying firearms in schools precedes an increased risk of African American youth suicide by
firearm and the African American/white racial disparity. I will achieve my Aims by using
longitudinal, publicly available data and apply an innovative approach that combines
epidemiological and econometric methods.
I (Abhery Das, applicant) have an MHS in Mental Health and am pursuing a PhD in Public
Health at University of California, Irvine (UCI). I am uniquely positioned for this fellowship
because of my strong background in psychiatric epidemiology and experience working with
mental health populations. The F31 award will allow me to 1) Develop knowledge on utilizing
public policy as a tool for suicide prevention; 2) Situate my research with a racial disparities
theoretical and empirical framework; 3) Advance proficiency in policy analysis and econometric
methodology; and 4) Foster academic professional development. Training activities will include
workshops, and seminar series, in addition to independent studies with my mentoring team and
a monthly, in-person meetings with Drs. Bruckner, Tita, and Owens. The fellowship will be
implemented in Public Health at UCI, which is an ideal training environment due to its strong
history of mentorship and interdisciplinary collaboration. This fellowship will be mentored by: Dr.
Tim Bruckner (Sponsor, psychiatric epidemiology), Dr. George Tita (Co-Sponsor, gun violence
reduction), Dr. Lonnie Snowden (consultant, racial disparities in mental health), and Dr. Emily
Owens (consultant, expert in econometrics and criminology). The fellowship will equip me with
knowledge, analytic tools, and professional competencies necessary to achieve my long-term
goal of leading independent investigations in mental health and public policy.

Public health relevance
PROJECT NARRATIVE The proposed research will evaluate, at different levels of influence, whether exposure to firearms precedes an increased risk of suicide by firearm among African American youth and the emerging racial disparity. I will examine two firearm-related factors: 1) state-level safer storage policies; and 2) firearm carrying practices, at the county level. This work holds relevance to mental health and public policy because it will estimate the potential roles of state policy, firearm safety, and firearm possession on the troublingly high rate of suicides by firearm among African American youth.